Task B14: Production of Well Characterized Challenge Material (WCCM) for Viral Pathogens

This contract provides for the development and standardization of non-human primate models of infectious diseases, and may include efficacy testing of candidate products, including biodefense pathogens and GLP studies to support licensure.